Precision Medicine Data Integration Core

Core B Precision Medicine Data Integration
PROJECT SUMMARY
Rheumatic diseases are heterogeneous in phenotypes, kinetics of events and trajectory, and
response to therapy. Defining relatively homogenous disease subgroups can foster identification
of patients who share underlying pathophysiologic mechanisms, risks of complications and
response to distinct therapeutic strategies – thereby laying a critical foundation for developing
precision medicine approaches to the rheumatic diseases. As approaches that utilize multiple
clinical and biologic characteristics to subgroup patients will likely improve our predictive
capability, it is critical to harness tools and technologies that allow aggregation and harmonization
of multiple streams data. Johns Hopkins Medicine has built a system for big data capture,
aggregation and harmonization. This tool, known as the Precision Medicine Analytics Platform,
captures high quality longitudinal data including deeper phenotypic data at the point of care,
granular results from diagnostic systems and measurements from outside the health care
environment. In this proposal, we seek to bring these tools and technologies to our rheumatology
subspecialty centers in Lupus, Vasculitis, Rheumatoid Arthritis, Psoriatic Arthritis, Scleroderma,
Myositis, Sjogren’s syndrome, Lyme, and Cancer Immune-Related Adverse Events to accelerate
research in the rheumatic diseases. The Specific Aims of the Precision Medicine Data Integration
Core are to: 1) facilitate and accelerate research study implementation, while ensuring stringent
research ethics and data security practices; and 2) transform data collection methods to harness
institutional “big data,” improve efficiency and enable remote study progress. The Core is led by
experts in research program building, research ethics and data security practices, and data
capture and harmonization methods.